Alzheimer's Disease and Related Disorders Treatment and Outcomes in America: Changing Policies and Systems.

PROJECT SUMMARY
The complex health care needs, poorer outcomes, high spending, and sociodemographic composition of the
population living with Alzheimer's Disease and Related Dementias (ADRD) pose serious challenges to
families, providers, and health systems and have important implications for health equity. Although the
population living with ADRD is expected to triple by 2050, many recent policy changes aim to maximize the
value of care for the “average” patient, without specific consideration of their consequences for high-cost, high-
need populations, such as those with ADRD. The P01 project will undertake four synergistic projects testing
the effect of recent national policies and payment changes on persons with ADRD in different states of disease
progression, in different care settings, and exposed to different policies. Project 1 seeks to determine the
effects of Medicare Advantage (MA) contract terminations on outcomes for enrollees with ADRD. Project 2
examines the impact of a federal policy to suspend Medicaid redeterminations on health outcomes for people
with ADRD. Project 3 evaluates the impact of the MA Hospice Carve-In policy on end-of-life care for persons
with ADRD. Finally, Project 4 evaluates the impact of a home health payment change on access and outcomes
of patients with ADRD. Each project aims to understand differential effects of financing and payment policies
among persons with ADRD by race, ethnicity and socioeconomic status and/or focus the analysis on patients
with low income or other social risk factors. All projects rely upon the Primary Data Collection and Partner
Engagement Core (Core B) and the Data Management and Methods Core (Core C). Core B uses qualitative
methods to gather perspectives from healthcare providers, payers, care partners, and persons living with
ADRD themselves. This will generate critical information about how organizations interact to enact policies and
implement practices that affect healthcare choice, access, use, and outcomes for persons with ADRD. Core C
will make important contributions on three key challenges related to health policy research in ADRD: (1)
accurately identifying the presence of dementia among enrollees in MA plans, (2) developing novel
approaches for causal inference study designs in the aftermath of large-scale shocks stemming from the
COVID-19 pandemic, and (3) integrating data across multiple payers, and institutional and community-based
care. Our robust dissemination plan includes updating and maintaining http://www.ltcfocus.org, a web-site
designed for federal and state policy makers and news media with health and aging interests; and working with
our Strategic Partner Engagement Panels and National Advisory Committee to maximize the impact and
relevance of our findings. Our project will provide timely, novel and rigorous evidence about the impact of
recent payment and financing policy changes for persons living with ADRD and inform policies that improve
care and promote health equity for this important population.

Public health relevance
NARRATIVE This Program Project seeks to examine the impact of recent national policies and payment changes on older adults living with Alzheimer's Disease and related dementias (ADRD) in different states of disease progression and in different care settings. Understanding these effects is crucial to document potential unintended consequences and inform policies that enhance access to healthcare, reduce burden on patients and families, improve quality of care, and advance health equity.